Communications Core

PROJECT ABSTRACT
The K-INBRE Communications Core was developed to bolster the K-INBRE's efforts to coordinate a multi-
pronged approach to expanding and advancing biosciences education and research among Kansas science
researchers, educators, and students. With K-INBRE partner institutions and participants dispersed
geographically across Kansas and Oklahoma, the Communications Core originally had the important and
complex role of operating and maintaining K-INBRE's technical network, and facilitating operational
communications of the program. As the Communications Core has grown, the K-INBRE Communications Core
continues to expand its role and services for K-INBRE and the IDeA program. The Communications Core is now
a central resource for network faculty, students and mentors to engage in a diverse array of professional
development and engaged scholarship activities. For the new grant cycle, the extensive work will continue with
new emphasis on the development of a robust data management, evaluation and scholarship initiative for the
program. More specifically, the following 4 Aims are proposed for the Communications Core: 1) evaluating the
effectiveness of programmatic and collaborative activities for continued improvement and scholarship of the
program; 2) advancing and leveraging the K-INBRE infrastructure for professional development of students and
faculty alike, filling a niche that may not be provided in degree programs or experiences; 3) enhancing the daily
operational and programmatic communication between faculty, students, and project investigators among the
partner institutions. Activities include undergraduate professional development, site visits, social media
management, and other strategies, and 4) highlighting the role and accomplishments of K-INBRE and IDeA on
bioscience education, research, faculty, and students engaged in the project. This has been accomplished
through a variety of means but particularly by professionally-produced videos that showcase both K-INBRE and
national IDeA faculty and students who have been highly successful in the program. A second IDeA video
focused on students is currently in production and will be unveiled at the NISBRE meeting in June 2018. Overall
the Communications Core has become an invaluable and critical resource for communications and data
acquisition.